Administrative Supplement to U54 AG079754: Midwest Murine-Tissue Mapping Center (MM-TMC)

ADMINISTRATIVE SUPPLEMENT GRANT SUMMARY
The Midwest Murine Tissue Mapping Center (MM-TMC) is focused on identifying, characterizing and spatially
mapping senescent cells (SnCs) in 5 different murine tissues – adipose, brain, liver, lung and muscle– from two
different mouse strains (C57BL/6J and FVB;C57BL/6J F1 mice) with age. To accomplish this, the MM-TMC
proposed in the parent application to use sc/snRNAseq analysis for identification and characterization of SnCs
at the transcriptional level and IHC/IF at the protein level and 10X Visium Spatial Gene Expression (SGE) and
Nanostring GeoMx Digital Spatial Profiler (DSP) for the initial spatial transcriptomic analysis along with a ~600
antibodies for analysis of the proteome. However, neither of these spatial transcriptomics platforms provides
single cell resolution. Low-abundance transcripts (~1.8 transcripts/cell) can be identified when a minimum of
~300 cells are spatially profiled, and high abundance transcripts can be identified in as few as ~50 cells. Thus,
we recently expanded our spatial mapping efforts to our new CosMx Spatial Molecular Imager with the currently
available CosMx Universal Cell Characterization RNA and Neuroscience panels that allow for the profiling of the
expression of 1000 curated RNA targets with subcellular resolution. CosMx, like GeoMx, is compatible with a
wide range of tissues, including FFPE. However, even though the 1000-plex CosMx panel can be customized
by adding up to 50 RNA targets to the panel, the transcriptional profiling is still incomplete, especially when
using the panel for analysis of SnCs in a wide spectrum of tissues including brain, adipose, liver, muscle and
lung. Thus, as part of this Administrative Supplement, we propose to apply the CosMx Whole Transcriptome
Mouse Panel to enable the detection and quantification of over 18,000 RNA transcripts at single-cell and
subcellular resolution. Importantly, the MM-TMC has early access to the Mouse Whole Transcriptome Panel in
the late Fall of this year that can be pre-ordered at a reduced cost. This unique early access from Bruker will
allow for completion of the proposed whole transcriptome spatial analysis in the 1 year time frame of the
supplement. The use of the CosMx Whole Transcriptome Mouse Panel will allow for greater identification and
characterization of SnCs as well as their paracrine effects on surrounding cells. The analysis also will allow for
determination of changes in cell identities or cell population alterations that correlate with age. Finally, the whole
transcriptome analysis will allow for a more detailed characterization of the paracrine signaling in regard to
ligands and their receptors between SnC and their SASP with neighboring cells. It is also important to note that
the results from the CosMx Whole Transcriptome Mouse Panel also will be compared to other platforms being
used by the MM-TMC (e.g., Visium, Visium HD, Xenium, GeoMx, and the 1000 RNA CosMx panel) in regard to
not only identifying, characterizing and spatially mapping of SnCs, but also for the characterization of the
paracrine effects of SnCs on neighboring cells.

Public health relevance
ADMINSTRATIVE SUPPLEMENT NARRATIVE Senescent cells (SnCs) with their inflammatory secretome play a causal role in aging and numerous age-related diseases. The Midwest Murine Tissue Mapping Center (MM-TMC) is focused on identifying, characterizing and spatially mapping SnCs in 5 different murine tissues, adipose, brain, liver, lung and muscle, with age. The proposed use of the CosMx Whole Transcriptome Mouse Panel for tissue spatial transcriptomics will allow for better resolution and sensitivity, which will greatly improve the identification and characterization of SnCs as well as determination of their effects on surrounding cells. This will lead to identifying better markers of SnCs as well as identifying novel therapeutic targets for depleting the SnC burden with age and disease.